Mechanisms of Synaptic Dysfunction in Parkinson's and Other Synuclein-Linked Diseases

ABSTRACT
Aggregation of -synuclein throughout the neuron, including at synapses, is a pathological hallmark of
Parkinson’s disease (PD), dementia with Lewy bodies (DLB), and variants of Alzheimer’s disease (AD).
Synaptic aggregation of -synuclein is strongly associated with cognitive deficits and dementia in PD
and DLB. The long-term goal of this project is to identify the cellular and molecular mechanisms that
give rise to -synuclein-induced synaptic deficits and to develop strategies for reversing them. While it
is generally agreed that -synuclein accumulation at synapses impairs synaptic vesicle trafficking, the
underlying mechanisms remain unclear, preventing the development of treatments for improving
synaptic function in PD and DLB. Over the last decade, we developed and implemented lamprey
reticulospinal synapses as a new model for studying how -synuclein accumulation impacts synapse
structure and function. Our lab was the first to discover that acutely introducing excess -synuclein to
synapses, mimicking increased expression in PD and DLB, inhibits synaptic vesicle endocytosis. This
result was subsequently corroborated at mammalian synapses. We then discovered that different
molecular species of -synuclein (e.g. monomers vs. dimers) cause distinct impacts on endocytosis,
emphasizing the need to understand how each species affects synaptic vesicle trafficking and the
underlying mechanisms. Experiments proposed in the parent award will significantly advance the field
by: determining how post-translational modifications of -synuclein alter its effects at synapses (Aim 1);
identifying how -synuclein oligomers purified from human PD and DLB brains affect synapses (Aim
2); and examining the underlying mechanisms with selective inhibitors of -synuclein membrane
binding and oligomerization (Aim 3). Experiments proposed in this post-baccalaureate diversity
supplement application expand the Aims of the parent award to include the impacts of these -
synuclein variants on synaptic mitochondria. The project is significant because it will substantially
increase our understanding of the impacts of excess -synuclein on synapses and local mitochondria,
including pathology-associated strains.

Public health relevance
PROJECT NARRATIVE These studies on -synuclein are relevant to public health because they will provide mechanistic insight into the synapse-based mechanisms underlying cognitive deficits and dementia in Parkinson’s disease (PD), dementia with Lewy bodies (DLB), and variants of Alzheimer’s disease (AD). These studies focused on -synuclein at synapses will significantly advance our knowledge of early stages of disease pathogenesis, which is complementary to studies on protein aggregation and neurotoxicity mechanisms. In addition, the proposed work will also provide critical knowledge on the interplay between -synuclein and synaptic mitochondria, thus impacting our understanding of PD and DLB disease pathogenesis, as well as other conditions where synapse function is compromised such as brain and spinal cord injury, neuromuscular disorders, and stroke.